Characterization of Novel Signaling Pathways Involved in Water Balance Disorders

PROJECT SUMMARY/ABSTRACT
Maintenance of water homeostasis is a vital function of the kidneys and is essential for adaptation to terrestrial
life. To reabsorb water effectively, vasopressin (VP) is released to induce aquaporin-2 (AQP2) phosphorylation
and actin cytoskeletal remodeling within kidney principal cells in the collecting ducts, which increases apical
membrane expression of AQP2. Dysregulation of AQP2 trafficking results in disorders of water balance;
decreased AQP2 membrane expression causes nephrogenic diabetes insipidus (NDI), whereas an increase in
plasma membrane AQP2 is associated with fluid retention in the syndrome of inappropriate ADH secretion
(SIADH), congestive heart failure and cirrhosis. While VP/cAMP/PKA is the major signaling pathway that
facilitates AQP2 membrane trafficking and water reabsorption, the process is in fact far more complex, and can
be induced or inhibited by other signaling pathways. One such “alternative” pathway involves the epidermal
growth factor receptor (EGFR), whose inhibition induces AQP2 membrane accumulation and phosphorylation
similar to VP, but bypasses V2R, cAMP and PKA. Therefore, the aims of this grant are to 1) define the
mechanism of crosstalk between VP and EGFR signaling pathways that regulate AQP2 trafficking; 2)
understand the role of AQP2 phosphorylation on cytoskeletal remodeling, and 3) characterize the roles of
novel signaling pathways in dysregulated water retention observed in patients with congestive heart failure, in
order to eventually design therapies to alleviate disease symptoms encountered in the clinic.
The training plan is progressive and is designed to move the PI Dr. Cheung through an initial stage of
completing and expanding her exciting, ongoing work on EGF/VP crosstalk (Aim 1), then moving on to a new
aspect of AQP2 cytoskeletal interactions not so far examined in the lab (Aim 2), before finally arriving at Aim 3
on heart/kidney interactions and water balance, which will complete her pathway to independence and be the
subject of her first R01 application. Dr. Cheung, supervised by her mentor Dr. Brown, will not only employ
existing technologies in the Program in Membrane Biology, but will also acquire important new techniques and
research training both from courses listed in her personalized training plan, and from the experts on her
advisory committee Drs. Joung (CRISPR/Cas9 gene editing) and Nahrendorf (surgery and mouse imaging for
heart failure). For professional career development, in addition to her award-winning mentor Dr. Brown, she
has Drs. Sylvie Breton and Jodie Babitt as successful female academic scientist role models. Moreover, the
MGH Nephrology Division chief, Dr. Ravi Thadhani will protect her research time from clinical duties, allowing
full immersion in her research. Her mentor, members of her scientific advisory committee, her Division chief,
the nurturing and collaborative environment in the MGH and Harvard community, will combine with a carefully
designed scientific plan to propel her toward her goal of becoming an independent R01 funded academic
nephrologist with expertise in inter-organ communications involved in water regulation.

Public health relevance
PROJECT NARRATIVE The kidneys are essential in water homeostasis and they play an integral role in inter-organ communication with the heart, liver and lungs, to regulate water in the body. Dysregulated signaling in the kidneys could contribute to dehydration or volume overload. Our work is focused on dissecting the underlying mechanisms that affect water regulation, and treating disorders of water balance.